Pseudo-hypoxic contributions to the tumor microenvironment in kidney cancer

ABSTRACT
Clear cell renal cell carcinoma (ccRCC), the most common type of kidney cancer, is characterized by deregulated
hypoxic signaling, metabolic defects, and complex immune cell infiltrate in the tumor microenvironment (TME).
Loss of the oxygen sensing gene, von Hippel Lindau (VHL), is a critical early event in ccRCC pathogenesis and
promotes stabilization of hypoxia inducible (transcription) factors (HIF) that upregulate pro-growth signaling
pathways, including aerobic glycolysis, regardless of oxygen availability. This phenomenon is termed “pseudo-
hypoxia.” The most frequent immune types affecting ccRCC are functionally impaired CD8 tumor infiltrating
lymphocytes (CD8 TIL) and metabolically enhanced tumor associated macrophages (TAM). Advancements in
immune oncology have led to improved overall patient outcomes with immune checkpoint blockade (ICB)
therapy; however, current modalities do not result in durable responses for the majority of ccRCC patients. I
propose that features linked to pseudo-hypoxic signaling promote alterations in cancer cell energetic
requirements that impact immune cell function in the TME and revealing these aspects may provide new
opportunities for therapy. My preliminary data indicate that Vhl loss favors a mature TAM myeloid phenotype
with enhanced mitochondrial metabolism in murine RCC, and this result is consistent with enhanced metabolism
observed in the myeloid compartment of human ccRCC. Additionally, TAM suppression of CD8 TIL may be
enhanced by specific interactions with cancer cells, though exact TAM functions are not understood. In this
proposal, I will test the hypothesis that pseudo-hypoxic signals from cancer cells in the TME
preferentially support a metabolically active TAM subset that promotes CD8 TIL suppression and that
inhibiting TAM activity will enhance the CD8 TIL response to ICB therapy. To test the cancer cell pseudo-
hypoxic effect on TAM function I have developed a fine needle aspiration-based patient-derived organoid (FNA-
PDO) model that recapitulates key factors of the TME in human tumors. I will also employ a pair of murine
syngeneic Renca cell line models (Vhl WT and Vhl KO) to address the impact of pseudo-hypoxia on the TME in
vivo. I will: (1) Test if pseudo-hypoxia supports a unique TAM phenotype with distinct metabolism; and (2), Test
the role of TAM in T cell suppression and ICB response. Ultimately, these studies will advance our current
understanding of kidney cancer biology by demonstrating mechanisms that shape the TME and highlighting new
strategies to improve immunotherapy.

Public health relevance
PROJECT NARRATIVE Unique genetic alterations promote a characteristic pseudo-hypoxic response and metabolic defects in kidney cancer cells. How these cell intrinsic mechanisms affect immune cell function and therapeutic resistance in the tumor microenvironment (TME) is not understood. This study will highlight a novel organoid model of kidney cancer and demonstrate the pseudo-hypoxic contributions on the TME to uncover new strategies for modulating and improving anti-tumor immune responses.